Development, Clinical Validation, and Readiness for Implementation of a Novel Mp1p D4 Poin Diagnosis of Talaromycosist of Care Test for Rapid

ABSTRACT
Talaromycosis caused by the dimorphic fungus Talaromyces marneffei (Tm) is an invasive mycosis endemic in
Southeast Asia. Tm causes a multi-organ disseminated infection that kills one in three affected persons with an
immunocompromised condition despite antifungal therapy. Persons with advanced HIV disease (AHD, CD4<200
cells/L) have the greatest risk and account for 90% of diagnosed cases globally. In highly-endemic countries of
Vietnam, Thailand, and China, Tm accounts for 18% of HIV-related hospital admissions and surpasses
tuberculosis and cryptococcosis as the leading cause of AIDS deaths. An impediment to reducing talaromycosis
mortality is our reliance on century-old diagnostic methods of culture which lack sensitivity and can take up to
28 days, leading to treatment delay and higher mortality. The scientific premise of this proposal is that early
diagnosis of talaromycosis (up to 16 weeks before culture diagnosis) using a novel point-of-care test (POCT) is
achievable, thus would enable early treatment and improve patient outcomes. We will engage multidisciplinary
team science to translate a first-in-kind POC technology from bench to bedside to policy, and we will pave a way
for an active screen-and-treat strategy to reduce disease burden and HIV mortality in Southeast Asia.
Our objective is to develop, optimize, and validate a novel POCT for early diagnosis and for screening of
talaromycosis, and to gather inputs from stakeholders to inform the development of a talaromycosis screening
program in people with AHD. Contact MPI Le and colleagues have developed a sensitive and specific enzyme
immunoassay (EIA) targeting a Tm-specific mannoprotein Mp1p abundantly secreted in patient blood and urine
during infection. She has shown that Mp1p is a more sensitive biomarker than blood culture for diagnosis and
can be detected up to 16 weeks before blood culture turns positive. MPI Chilkoti has pioneered the D4 POCT—
a self-contained immunoassay that can quantify Mp1p levels in <30 minutes. Herein, we propose the translation
of the Mp1p EIA onto the Mp1p D4 POCT to provide a rapid, cheap, and ultra-sensitive test for talaromycosis.
AIM 1: Develop and optimize a Mp1p D4 point-of-care test (POCT) for early diagnosis of talaromycosis in
human blood, serum, and urine.
AIM 2: Determine the clinical utility of the Mp1p D4 POCT as a rapid diagnostic tool for symptomatic
talaromycosis and as a screening tool for pre-clinical disease in two cohorts of patients with AHD.
AIM 3: Determine the cost-effectiveness, feasibility, and acceptability of implementing a public health
talaromycosis screening program.
Impact: This proposal will translate a novel POC technology from ‘bench to bedside to policy’, forging a paradigm
shift from passive treatment to an active screen-and-treat approach that will improve the individual patient
outcome and reduce disease burden at the population level. It will build important partnerships with the health
system and community and facilitate the implementation of a talaromycosis screening program in Vietnam.

Public health relevance
NARATIVE The goal of this proposal is to develop and validate a new point-of-care test for early diagnosis and screening of talaromycosis, a leading cause of AIDS-related deaths in Southeast Asia. We will also assess the costs and opinions from stakeholders to inform policy development. The test may allow doctors to begin treatment earlier which can prevent disease from developing or from progressing further into fulminant stage, thus improving patient outcomes and reducing mortality.